Caregiver decision making for seasonal respiratory vaccines for children

PROJECT SUMMARY
In the current post-Coronavirus Disease 2019 (COVID-19) pandemic era, the scientific community is preparing
for the need for seasonal vaccination campaigns similar to annual influenza vaccination to slow transmission.
Uptake of COVID-19 vaccines for children has been lackluster, mirroring a trend observed for seasonal
influenza vaccines among pediatric patients. The low vaccination rates for both COVID-19 and influenza
among children are starkly contrasted with the relatively stable, high rates for non-seasonal, childhood
vaccines, including hepatitis B, measles, mumps, rubella, polio, and varicella vaccines. These data support
findings that parents are more hesitant to vaccinate their children against influenza when compared to non-
seasonal, childhood vaccines, and the slow uptake of COVID-19 vaccines among children suggests that a
similar trend has emerged for COVID-19. These overarching trends suggest that the determinants of parental
hesitancy for seasonal respiratory vaccines (SRVs) may fundamentally differ from those for non-seasonal
vaccines, though this phenomenon has not previously been explored. This gap has significant implications for
the development of interventions to address SRV hesitancy. If the underlying determinants of vaccine
hesitancy differ for seasonal versus non-seasonal vaccines, the evidence-based interventions employed to
overcome vaccine hesitancy may not be transferrable to SRVs in the post-pandemic era. My long-term career
goal is design and implement high-fidelity interventions for addressing pediatric vaccine hesitancy as an
independently-funded investigator. The proposed project’s overall objective is to identify factors influencing
parental SRV hesitancy in the post-pandemic era to inform a targeted communication strategies intervention
for pediatricians tailored to address SRV hesitancy. We will accomplish the project objective through a mixed-
methods study with the following aims: 1) Identify determinants of parental SRV hesitancy; 2) Identify
pediatricians’ perceived challenges and facilitators of vaccine communication; and 3) Develop and pilot a
communication strategies curriculum for pediatricians tailored to address parental SRV hesitancy. This pilot
study has the potential to generate contemporary, evidence-based communication tools to minimize physician
burnout around vaccine discussions, and ultimately to promote pediatric SRV uptake. In the process, I will
advance my training by developing 1) expertise in health communication and behavioral science, 2) advanced
techniques in mixed methods design, 3) expertise in health communication interventions and implementation
science, and 4) leadership and professional development skills to translate my findings into clinical practice. In
summary, this research will help develop my expertise in mixed methods and behavioral interventions,
enabling me to become an independent investigator capable of developing and translating novel vaccine
hesitancy interventions to real-world clinical settings, with the ultimate goal of promoting widespread vaccine
uptake among children.

Public health relevance
PROJECT NARRATIVE Despite the importance of seasonal vaccination for preventing infections, hospitalizations, and deaths, COVID- 19 and influenza vaccination rates among children lag significantly behind coverage rates for non-seasonal, childhood vaccines, including hepatitis B, measles, mumps, rubella, polio, and varicella. As such, the determinants of parental hesitancy for seasonal respiratory vaccines may fundamentally differ from those for non-seasonal, childhood vaccines, which has significant public health implications for the development of interventions for addressing parental vaccine hesitancy in the post-pandemic era. The proposed project will identify the factors influencing parental hesitancy for seasonal respiratory vaccines, identify pediatricians’ perceived challenges and facilitators of vaccine communication, and develop and evaluate a targeted communication strategies pilot that may help to improve seasonal respiratory vaccine uptake among children.